Harnessing the Power of Experimental Genetic Crosses to Probe Drug Resistance in Malaria

ABSTRACT
The Administrative & Resource Sharing Core (Admin Core) based at the University of Notre Dame (UND) will
ensure that the Program Project grant (P01) MPI and Admin Core Director (AD) (Ferdig) and MPI (Vaughan)
are positioned to supervise and administer the P01. The Admin Core Directors (Ferdig and Button-Simons) will
oversee all project communications and sharing of all data and materials with the malaria research community
to maximize accessibility and reusability.
The Admin Core will facilitate communication and interaction between all groups and will thus ensure that the
three physically separate sites will function as a virtual single site. The ADs, MPIs and the Science Management
Team (consisting of one key post-doc from each site), with assistance from the Admin Core Program Manager
(PM), will function to coordinate the overall scientific direction and will monitor ongoing productivity of the P01
and communicate the activities to the Advisory Boards. In its administrative capacity, the Admin Core will
centralize program-wide information, provide administrative support to program investigators, and maintain
records relating to P01 progress. The MPIs will participate and manage at all levels of communication and are
responsible for all aspects of effective operations and collaborative decision-making with the Leadership Team
(LT). The MPIs and LT will coordinate the overall direction of the P01 with feedback from an Internal Advisory
Board (IAB), an External Advisory Board (EAB) and Panel of African Advisors (PAA). The IAB will consist of
distinguished expert faculty at the three performance sites (ND, TBRI and SCRI) and will evaluate ongoing
progress towards P01 goals and provide recommendations for alternative strategies to P01 activities if
modifications are indicated. The EAB will guide and evaluate the overall impact and productivity of the program
in alignment with the broader scientific community in the areas of the P01. The PAA will provide input on
questions of clinical importance in Africa and prioritization of crosses. The EAB will be formed in communication
with NIH Program advisors: the EAB and will consist of worldwide experts on classical genetics, linkage mapping,
systems biology, malaria and drug resistance. The PAA will consist of clinical and research scientists working in
Africa and will include representation from each country with emerging ART-R.
The Admin Core will centralize records for all data and materials created by the P01. The ADs and data sharing
team (Button-Simons, Li and Cheeseman) will ensure raw data are deposited to NCBI and processed data are
shared to VEuPathDB. Working with the ND Center for Research Computing and VEuPathDB we will ensure
tools are created specifically to make P01 data broadly accessible to the malaria research community building
on successful collaborations initiated as part of the original P01. The Admin Core will oversee the expansion
and authentication of key resources (including parents, bulk progeny and cloned progeny) for sharing with the
malaria research community. Resources will be available to the malaria research community upon request and
researchers will be encouraged to feed data and results into a shared data resource housed at VEuPathDB.

Public health relevance
NARRATIVE The Admin Core is responsible for management and communications of the P01 and will continue to utilize effective tools and practices to ensure personnel from the Admin Core, Core A, Core B, RP01, RP02, and RP03 work seamlessly together across sites. The Admin Core will partner with VEuPathDB to host an interactive data resource and develop tools to maximize data accessibility. The Admin Core will develop and maintain a repository of genetic cross progeny to share with the malaria research community.